Does Electrical Stimulation Enhance the Capacity of Neural Stem Cell Transplants to Improve Recovery from Chronic Spinal Cord Injury

Project Summary/Abstract
Stem cell (StC) treatments have enormous potential to restore function after chronic spinal cord injury (SCI)
due to their regenerative potential. These cells provide trophic factors that support neurite outgrowth and
replace lost cells through differentiation into neurons and glia. Despite many encouraging advances, StC
therapies still face severe limitations, including the negative effects of the lesion environment on transplanted
cells and insufficient integration of differentiated neurons and glia into existing neural circuits. Consequently,
StC therapies have produced only modest behavioral improvement in animal studies and human trials for SCI.
Several forms of electrical stimulation (ES) have led to improved function after SCI in animals and humans
with partial SCIs. These include repetitive stimulus pulses delivered epidurally or intraspinally, and with either
open- or closed-loop protocols. These approaches have led to improved motor and autonomic function by
promoting neural plasticity in spinal and descending pathways. Electrical polarizations using either direct or
oscillating field stimulation can reduce inflammatory responses, facilitate myelin regeneration, enhance
neuronal excitability, and cause directed axonal growth.
The effects of StC and ES therapies seem complementary. However, there are few studies that have
combined StC transplants and any form of spinal ES as a treatment for SCI, and therefore it is not known if the
two approaches can magnify or interfere with the rehabilitative benefits and potential of each. The objective of
the proposed project is to begin an exploration of the interaction of these two promising treatments. The study
will begin a new line of research whose long-term goal is to develop novel combinatorial therapies that will
advance clinical practice and improve the quality of life of individuals living with SCI.
We will study a rat model of contusive injury of the cervical spinal cord, and transplant rat embryonic neural
stem cells derived from the spinal cord since these cells adopt normal motor and sensory fates and support
regeneration in animals with SCI. We will apply three different forms of ES that in previous studies have
improved the behavior of animals and/or humans with chronic SCI. Our primary goal will be to determine if ES
supports the survival and differentiation of StCs, enhances the growth over long distances and synapse
formation of axons of new neurons, and promotes the integration of the differentiated cells into spared neural
circuits. We will also investigate whether the combined treatments produce improvement in the rats’ motor
performance, although the scope of an R21 project will limit our ability to study this issue in depth. If the project
is successful, future studies will focus on whether combined StC-ES therapies provide improvements in
function beyond that achieved by each treatment alone.

Public health relevance
Project Narrative The goal of the project is to begin an exploration of the effect of three different forms of electrical stimulation on rat embryonic neural stem cell transplants in a rat model of spinal cord injury. The hypothesis addressed in the proposal is that electrical stimulation will improve the survival and differentiation of stem cells in the injured spinal cord, and promote functional integration of the new neurons and glia into the host nervous tissue. In the long-term, the project may advance the development of novel combinatorial treatments that will improve the quality of life of individuals living with spinal cord injury.